Subpopulations of Pancreatic Cancer Cells Defined by Glycan Markers

PROJECT SUMMARY
A difficulty in the development of effective treatments against pancreatic cancer is heterogeneity within and
between tumors; a subset of cancer cells, rather than all cells in a tumor, is responsible for the behaviors of
invasiveness and resistance to death. Drugs that act on the aggressive subpopulations promise to be more
effective than drugs that act on the bulk of a tumor, but research to identify such drugs is hampered by the lack
of biomarkers to detect, isolate, and study the aggressive subpopulations.
The goal of this project is to identify biomarkers of aggressive subpopulations of pancreatic cancer
cells. We hypothesize that distinct subtypes of pancreatic cancer cells exist, and that they differ in their
invasiveness and resistance to death. We found support for this hypothesis in previous research through the
identification of glycan biomarkers of subpopulations of cancer cells with differences in molecular
characteristics and behaviors. We will build on the previous results to fully test the possibility that specific
glycan markers can be used for detecting subtypes of cancer cells. We posit that aggressive subtypes will be
associated with poor outcomes, and that they will display high invasiveness and resistance to death in model
systems. To enable a complete evaluation of the candidate markers, we will employ valuable tissue resources
such as primary tumors, patient-derived xenografts, and tumor organoids, and we will apply unique and
powerful experimental systems—multimarker immunofluorescence and MALDI glycan imaging.
Biomarkers that identify the aggressive subtypes of pancreatic cancer cells could pave the way for the
development of truly effective therapies. They would provide a way to determine which model systems, or
which cells within the models, are the important ones to target, and they would provide companion diagnostics
to guide and monitor the use of the targeted therapies. Drugs arising from such research would, for the first
time, strike at the critical point—the subset of cells giving rise to the lethal nature of the disease. We are in a
good position to produce significant results given the leads from previous research, our technologies and
resources, and the team of clinical, technological, and statistical experts.

Public health relevance
PROJECT NARRATIVE A hindrance to the development of successful treatments against pancreatic cancer is the significant heterogeneity in cancer cells within and between tumors. Biomarkers to identify subtypes of pancreatic cancer cells could enable the development of drugs against the aggressive subtypes and provide guidance to the selection of current treatment options. We are seeking to identify biomarkers for that purpose.